Role of Decidual Extracellular Vesicles in Mediating Placental Insufficiency

PROJECT SUMMARY
Placental insufficiency- caused by deficient extravillous trophoblast invasion and/or syncytiotrophoblast nutrient
transport and inadequate blood flow to the placenta- is a central hallmark in numerous obstetrical diseases,
including fetal growth restriction (FGR) and preeclampsia. These diseases each affect 3-8% of pregnancies
worldwide and have lifelong complications for both the mother and baby. While placental insufficiency is a
common pathological feature, whether this arises from intrinsic placental developmental defects or altered
maternal signals, eg. during viral infection that increases FGR and preeclampsia risk, remain unknown.
Findings from our lab and others have implicated maternal endometrial dysfunction in the early
pathophysiology of FGR and preeclampsia. Endometrial stromal cells are the major cell type of the
endometrium and they undergo decidualization spontaneously every month in preparation for pregnancy.
Decidualized endometrial stromal cells (decidual cells) promote endometrial receptivity and regulate
placentation and vascular remodeling at the maternal-fetal interface. These effects can be mediated by
decidual secretion of extracellular vesicles (EVs) that contain specific miRNA cargos. We have shown that
exposure to viral double-stranded RNA (dsRNA) impairs decidualization and alters the miRNA cargo of
decidual EVs. These decidual cells and EVs negatively impacted trophoblast stem cell differentiation and
angiogenesis in vitro and in vivo. Based on these findings, our central hypothesis is that uncontrolled uterine
inflammation alters decidual EV miRNA cargo which impairs trophoblast stem cell differentiation to
syncytiotrophoblast while increasing uterine vascular dysfunction, leading to placental insufficiency.
We will take a targeted hypothesis-driven approach to examine the effects of decidual EVs, and EV-associated
miR-30a-5p and miR-206, on trophoblast stem cell differentiation, syncytiotrophoblast function (Aim 1) and
uterine vascular functions (Aim 2) using physiologically-relevant trophoblast models, 3D models of
angiogenesis and ex vivo vascular studies. Finally, we will confirm these findings clinically by examining
markers of decidual inflammation and altered EV cargo in biospecimens from patients with FGR and
preeclampsia (Aim 3). Successful completion of this project will highlight the importance of maternal decidual
health for pregnancy success and reveal decidual EVs as an early pathological player in the pathogenesis of
FGR and preeclampsia. The long-term goal of this research program is to identify new opportunities for the
development of early biomarkers and therapeutic strategies to lessen the immediate and lifelong impacts of
placental insufficiency.

Public health relevance
PROJECT NARRATIVE Placental insufficiency underlies numerous obstetrical diseases, including preeclampsia and fetal growth restriction, where the early pathogenesis remains unclear and diagnostic and therapeutic options are limited. We will examine the contributions of the maternal decidua and their extracellular vesicles in mediating early trophoblast stem cell differentiation and maternal vascular adaptations for pregnancy, and how this is perturbed during infection. A better understanding of the maternal decidual contributions to a healthy pregnancy provides critical knowledge for the future development of biomarkers and therapeutic strategies to improve lifelong outcomes for mothers and babies worldwide.